Administrative Core

PROJECT SUMMARY (Administrative Core: Maier, Zhang, Ramirez-Andreotta, Isaacs)
The University of Arizona Superfund Research Program (UA SRP) Administrative Core is the “glue” that holds
the many parts of our Center together making the “whole” of our Program greater than the sum of the individual
Research Projects and Cores. The Administrative Core integrates the many components of our Program to meet
the needs of the overall NIEHS Superfund Research Program, our stakeholders, and our community. The
Administrative Core encompasses both the management aspects as well as the creative development of our
Center. The management component includes the responsibilities for the supervision, direction, planning, and
coordination of the UA SRP, as well as communication with stakeholders and financial accountability. The
development component involves seeking innovative ways to increase the impact of our Center including building
partnerships within the University of Arizona, with our sister SRPs, and with our stakeholders (NIEHS,
Environmental Protection Agency, Agency for Toxic Substances and Disease Registry, State agencies,
communities, and the mining industry). The overall goal of our Center is to address the management,
remediation, and health effects of environmental pollutants, namely arsenic and other metals, related to the metal
mining industry in the US Southwest. Our Administrative Core objectives are to: (1) manage and coordinate the
research projects and support cores to ensure attainment of the Center’s proposed research, training, and
translational objectives; (2) promote the exchange of scientific information at all levels through interaction with
NIEHS and stakeholders and the translation of our research products to risk assessment, intervention, education,
and hazardous waste site management and remediation; (3) creatively leverage our Center to expand our
research base and our ability to test and transfer new exposure assessment, intervention, and remediation
technologies; and (4) facilitate the UA SRP to serve as a global resource for human and environmental health
issues associated with metal mining.

Public health relevance
PROJECT NARRATIVE (Administrative Core; Maier, Zhang, Ramirez-Andreotta, Isaacs) The primary tasks of the University of Arizona Superfund Research Program Administrative Core include guiding our Center as a whole to define the human and environmental health risks associated with metal mining in arid environments. The Administrative Core also leads our Center in the development of innovative, cost-effective, long-term, evidence-based solutions that will effect change in the current mining industry practices and ensure the protection of human health and the environment. The final task of the Administrative Core is to coordinate the communication of Center findings to our stakeholders including NIEHS, our sister Superfund Programs, Federal, State, and Tribal regulatory agencies, the mining industry, and affected communities.